Methods Core for Study and Data Collection, Design, Support and Dissemination

PROJECT SUMMARY/ABSTRACT - Cambridge Health Alliance
ALACRITY for Early Screening and Treatment of High Risk Youth (eSToRY)
Methods Core for Study and Data Collection Design, Support and Dissemination
The Methods Core will be the linchpin of the eSToRY Center, bringing together a powerful mix
of clinical and sociocontextual data, the latest rapid computer adaptive testing of
psychopathology and symptomatology, a suite of rigorous in-depth community-engaged
qualitative techniques and quantitative methods applied to large administrative and clinical trial
data, and an emphasis on community-based participatory research to increase the relevance
and appropriateness to racial/ethnic and language (REL)-minority youth and families. The
backbone of the Methods Core is a team of renowned methodological experts and a large
clinical-sociocontextual dataset, linking >600,000 REL-diverse patients' electronic health
records (EHR), insurance claims, criminal justice, neighborhood- and individual-level social
determinants of health (SDOH) data, and computer adaptive psychiatric testing. These merged
data comprise an extensive data warehouse that will facilitate novel solutions to intractable
mental health problems.
In Aim 1, we will establish a HIPAA-compliant integrated clinical-sociocontextual data
warehouse for use in early identification, prevention, and treatment of mental illness among
REL-diverse youth. In Aim 2, we will provide methodological support to three R34 projects and
pilot projects, employing the latest rigorous quantitative and qualitative methods to increase the
relevance and understanding of mechanisms of racial/ethnic and language disparities in access
and quality of mental health care. In Aim 3, we will engage and solicit participation of individuals
from diverse backgrounds, including community stakeholders, to assure the relevance of the
research projects, interpret results, develop interventions, and disseminate findings through a
strong web of clinical-, school-, and community-based connections.